NICHD - SCIENTIFIC AND TECHNICAL CONSULTING SERVICES.

The objective of the order request is to obtain preclinical and/or clinical (e.g., Phase 1) multipurpose prevent technologies (MPT, contraceptives with anti-infective properties: e.g., anti-HIV) related consulting services for a range of product development considerations. This includes developing contraceptives technologies with anti-infective properties against pathogens such as HIV, Bacterial Vaginosis, Chlamydia, etc. supported by NICHD’s Contraception Research Branch. These services shall provide expert consultation to NICHD staff on pre-clinical, Phase 1 clinical, ethical, policy, and regulatory issues related to NICHD’s extramural contraceptive research portfolio and other related product development related areas, as directed by NICHD staff.